PET imaging of viral infection

Many viruses sustain a parasitic lifestyle by exploiting host cell supplies of nucleotides for replication. The
manifestation and progression of Corona Virus Disease 2019 (COVID-19) caused by SARS-CoV-2 (SARS2),
an RNA virus, is accompanied by the expansion of the virus in the infected host using host's machinery. The
rapid SARS2 expansion requires augmented RNA synthesis via the salvage pathway of RNA synthesis, most
especially in the non-dividing cells that are the targets of SARS2 infection. This provides an opportunity to
trace the status of viral infection if an imaging tracer that is indicative of viral RNA synthesis is available.
Similar to the host, viral related RNA synthesis (viral genomic RNA or viral messenger RNA) occurs in
three stages: initiation, elongation and termination. We will focus on the elongation of viral related RNA
synthesis, which is the repeated addition of a nucleoside monophosphate (NMP) to the 3’ end of the growing
RNA chain. Since SARS2 requires massive amounts of host cell uridine, 1/3 of its genome is uridine, uridine is
moreover required for sub-genome positive strand RNA synthesis/viral function. Accordingly, radiolabeled
uridine shall be used to track pyrimidine metabolism by PET imaging for augmented RNA synthesis under
SARS2 infection. However, the specific salvage pathway of uridine metabolism for incorporation into viral RNA
synthesis was not up-regulated in SARS2 infected tissues. Yet, 5-FU can be converted directly into uridine
monophosphate (UMP) for incorporated into RNA. We therefore propose to use F-18 labeled pro-drug 5-
fluorouracil (5-[18F]FU, the same molecule as 5-FU with isotopic substitution of F-19 by F-18) instead.
Still, the rapid catabolism of 5-[18F]FU obscures interpretation of the PET images until the addition of
eniluracil (5-ethynyluracil) that prevents the catabolism of 5-[18F]FU to obtain meaningful PET images of 5-
[18F]FU uptake. Consequently, we propose to re-purpose 5-[18F]FU for PET imaging of SARS2 infection, and
will use the same eniluracil to transiently maintain the integrity of 5-[18F]FU during the proposed PET imaging.
We will test PET imaging with 5-[18F]FU using the readily available and clinically relevant model of mouse
hepatitis virus (MHV) infection. MHV, a murine coronavirus very similar to SARS2 in structure, can cause a
wide range of diseases in the mice and rats, including hepatitis, encephalomyelitis, enteritis, and, respiratory
diseases. Many of these same organs were similarly affected during human SARS2 infection even though the
acute lung injury related mortality symbolized COVID-19 in the public perception.
Clinical utility of 5-[18F]FU PET imaging would be complementing PCR-based testing of COVID-19 (gold
standard) or CT-based assessment (non-specific evaluation) of related lung disease. It could also be used to
facilitate new anti-viral drug development (beyond remdesivir) for optimizing therapeutic dose and treatment
duration, and for treatment monitoring in the future.

Public health relevance
Our study investigates a radiolabeled pro-drug 5-fluorouracil (5-[18F]FU) for its integration into viral RNA synthesis for PET imaging of SARS2 infection, which causes Corona Virus Disease 2019 (COVID-19). Once developed and validated, great clinical value can be derived from this practical clinical tool that indicates in real-time the likely sites and extent of infection, and the impact of candidate therapeutics, including for optimizing therapeutic dose and duration.